Validation of pre-clinical models of musculoskeletal healing following trauma

With aging, there is a precipitous loss in activities of daily living (ADLs), and a decline in the function and repair
of musculoskeletal (MSK) tissues is a significant contributor to this loss. Veterans are particularly vulnerable to
a reduction in ADLs because the likelihood of experiencing severe trauma that injuries multiple MSK tissues is
higher in military service than in civilian life. While these severe traumatic injuries are less life-threatening now
than in the past, complications of MSK regeneration arise and lead to the requirement of assisted living later in
life. Thus, there is a strong need for preclinical models of polytrauma injury that facilitate studies into the
mechanisms connecting poor MSK repair to fewer ADLs. Several such models exist in the literature, but none
have been validated with respect to the key clinical problems associated with impaired MSK regeneration,
namely delayed fracture healing, muscle fibrosis or soft tissue calcification, osteoporosis, cognitive impairment,
pain sensitivity, and hyper-inflammation. Therefore, the goal of this project is to validate a murine model of
combined injuries – skin burn, muscle injury to the lower hindlimb, and fracture of the femur mid-shaft – for its
ability to recapitulate many of the problems that reduce ADLs. In Aim 1, we will compare the healing response
of adult, transgenic mice among 3 injury groups: i) single femur fracture or single muscle injury in the lower
hindlimb, ii) femur fracture plus single muscle injury, and iii) combined femur fracture, muscle injury, and skin
burn. These transgenic mice express luciferase when the NFκB regulatory element is active, thereby allowing
us to image tissue inflammation by bioluminescence. To validate the model, we will determine if fracture healing
is delayed at 28-days post injury (DPI) and muscle fibrosis persists at 42-DPI in the polytrauma mice compared
to the single injury mice. In Aim 2, using the same mice in Aim 1 but adding sham littermates (no injury), we will
compare the effect of injury on degeneration among 5 groups: i) sham control, ii) single femur fracture, iii) single
muscle injury in the lower hindlimb, iv) dual injury to bone and muscle, and v) combined polytrauma injury with
skin burn. Starting at baseline (before injury) and at post-injury intervals, areal bone mineral density (dual-energy
X-ray absorptiometry) of the uninjured femur, whole-body weight (mass), cognitive function (novel object
recognition test), pain sensitivity (allodynia and hyperalgesia to mechanical stimuli), duration of sleep (cage
activity), and mobility (voluntary wheel running plus gait analysis) will be assessed until 42-DPI. Additionally, the
contralateral, uninjured femur and the lumbar vertebral body will be imaged ex vivo by μCT and subjected to
load-to-failure tests in three-point bending (femurs) or in compression (vertebra) to determine whether the cortical
structure, trabecular micro-architecture, volumetric bone mineral density, and strength are different among the
groups. To validate the model of combined polytrauma with respect to degeneration, bone loss and bone strength
will need to be higher and lower in the combined injury group than in the no-injury, sham group, respectively. In
addition, our other validation goal is to demonstrate that the combined MSK injury to bone and muscle with skin
burn also impairs memory, causes hypersensitivity to pain, reduces duration of sleep, and reduces movement
as these are clinical complications of polytrauma. In Aim 3, blood samples will be collected at euthanasia from
the mice in Aim 1 (28-DPI and 42-DPI) as well as from additional NFκB reporter mice at earlier time points (1-
DPI, 3-DPI, 7-DPI, and 14-DPI) so that we can quantify the temporal changes in the hyper-inflammatory response
to injury. Prior to euthanasia, we will image all mice in vivo to assess tissue inflammation, and after euthanasia,
we will image individual organs ex vivo. To validate the model, systemic hyper-inflammation and tissue
inflammation will occur for a longer period time in the polytrauma combined group than in the single injury group.
With a validated murine model of polytrauma that possesses many of the clinical problems associated with poor
regeneration of musculoskeletal tissue, future studies can identify and investigate mechanisms, therapeutic
strategies, and prognosticators that will help Veterans maintain activities of daily living as they age.

Public health relevance
As Veterans age, they can lose the ability to perform activities of daily living because they are susceptible to poor or inadequate repair of musculoskeletal tissues such as muscle, ligaments, and bone. A major contributor to this poor repair is a severe, traumatic injury that affects multiple limbs. Despite known consequences of compromised healing of musculoskeletal tissues, a pre-clinical model of polytrauma has not been validated to recapitulate the multiple factors limiting activities of daily living, namely delayed fracture healing, soft tissue fibrosis and calcification, bone weakness, metabolic dysfunction, and cognitive impairment. If successful, this project will validate such a murine model that combines skin burn injury, soft tissue injury of the lower hindlimb, and a fracture of one femur midshaft to produce a hyper-inflammatory response. All injuries are well controlled favoring reproducibility. If validated, the mouse model can be used to study mechanisms by which severe injury causes common clinical complications among Veterans.